University of Washington Genomics Research Training for Data Scientists

Project Summary
In support of the NHGRI Strategic Plan to Diversify the Genomics Workforce, we propose the University of
Washington Genomics Training for Data Scientists program (UW-GRTDS). This interdisciplinary program
provides masters students in data science from underrepresented minority (URM) backgrounds with paid
research experiences in genomics research laboratories at UW. During their research experience, students will
receive mentorship from their genomics research faculty mentor, a data science faculty mentor, the
UW-GRTDS Program Manager, and the Genome Sciences trainee community. UW-GRTDS students will be
welcomed into the genomics training environment by participating in career development and networking
events with other graduate students from URM backgrounds. The long-term objective of this program is to
create a more inclusive environment for URM data scientists in order to encourage them to pursue careers in
genomics research. Throughout this program we will identify and share strategies to enhance and support
similar programs in order to serve the formation of a more diverse genomics workforce.

Public health relevance
Narrative The genomics workforce faces a shortage of people with data science skills and is also lacking diverse representation. These problems impact the quality of research being conducted, and the lack of diversity leads toward both explicit and implicit bias within genomics data sets and among those conducting research. The UW-GRTDS will address these problems by recruiting diverse trainees with data science skills, thereby helping to diversify the genomics workforce and promoting a higher quality of genomics research for the benefit of human health.